SPORE in Breast Cancer

This is the competitive renewal for year 30-34 of the UNC Breast Cancer SPORE. SPORE goals and aims have been reinvigorated every five years with advice from a robust advocate group and an insightful series of external and internal advisors. However, the emphasis on environment and demographics including rurality, genomics, and other risk factors in breast cancer disparities has been consistent. Genomic technology and analytic capacity, subtyping/biomarker research and therapeutic resistance have also been consistent, as has the recruitment and mentoring of junior faculty. Career development has returned dividends, with multiple SPORE leaders being previous recipients of CEP funds. One constant since 1992 is a biospecimen, epidemiologic, and clinical data-rich population-based Carolina Breast Cancer Study (CBCS). CBCS Phase 3 (3,000 new cases, 2008-2013) has collected ten years of follow-up; CBCS 4 will recruit an additional 3,000 new cases, again with oversampling of younger (50% of the study population) women, who are typically understudied in genomic and health services research. CBCS has made seminal contributions to our understanding of Triple Negative Breast Cancer (TNBC) and other subtypes in multiple populations with 230+ papers published (47 from this cycle), many high impact and heavily cited. CBCS will focus on a cells-to-society model wherein tumor biology and immune response are part of a complex system that includes differences in health care access and environments. All 4 projects, which share a focus on TNBC that disproportionately afflicts young women, will contribute to understanding across this spectrum. Continued institutional investment, averaging $2-$2.5M yearly, allows the renewed SPORE to: i) Incorporate new technologies and methods; ii) Develop infrastructure for population and translational research; and iii) Support junior and mid-level faculty from the population, basic, and clinical sciences. In the past 5 years the CEP has supported 17 new faculty who successfully competed for foundation, cooperative group, and NCI funding. DRP funded multiple collaborative projects (two are among the 4 Projects in this application). With EAB, Advocate, and Executive Committee input, the MPIs Perou and Carey selected four Projects, focusing on determinants of health, biomarkers, immune-based therapeutics and TNBC therapeutic resistance: Project #1 – Carolina Breast Cancer Study (CBCS): Linking Tumor Biology and Demographics to Outcomes (Troester PhD, and Reeder-Hayes MD, MBA MSc), Project #2 – Determinants of Response and Resistance to DNA-Damaging Radiation Plus Immunotherapy Combinations in TNBC (Gupta MD, PhD, and Vincent MD), Project #3 – Development of Novel Therapies and Biomarkers for TNBC (Perou PhD, and Carey MD, ScM), Project #4 – Activity of CAR-T Cell Therapy for Patients with Metastatic TNBC (Dotti PhD, Serody MD, and Abdou MD).

Public health relevance
The UNC Breast Cancer SPORE submits its revised Year 30- 34 competitive renewal based upon substantial productivity and impact, particularly in the areas of determinants of health, genomics and translation as well as remarkable CEP success with recruitment of 17 new faculty. Continued evolution, innovation and institutional commitment mark the 2 continuing and 2 new projects, all linked by the theme of immune analysis and therapeutic intervention in triple negative breast cancer. The renewal includes the 30th anniversary of the SPORE funded Carolina Breast Cancer Study and the launch of Phase 4 (3000 new cases, 50% younger), with biospecimens, determinants of health and clinical data in this new era of breast cancer therapy.